Role of GM-CSF and impaired lipid metabolism in the pathogenesis of PAP

PROJECT SUMMARY/ABSTRACT
Dr. Elinor Lee is a Pulmonary and Critical Care physician who is greatly interested in the role of lipid metabolism
in surfactant homeostasis and pulmonary diseases. Dr. Lee is focused on mechanistic studies exploring the
paradigm-shifting hypothesis that lipid dysregulation contributes to the pathogenesis of pulmonary alveolar
proteinosis (PAP). Her long-term goal is to establish an independent research program as a physician scientist
in the field of lipid biology and PAP and eventually, other pulmonary diseases. She is supported by her primary
mentor, Dr. Tarling, a leader in lipid biology and inflammation, as well as her co-mentors and advisors who will
provide their multidisciplinary expertise in training Dr. Lee in the theoretical and technical aspects of lipid
metabolism and immunology. Through UCLA’s Clinical and Translational Science Institute (CTSI), Dr. Lee will
have access to numerous career development seminars that address such topics as grant writing, manuscript
preparation, and ethical research. She will also take graduate courses to obtain further training in gene editing,
immunology, lipid metabolism, and biostatistics. Dr. Lee has the full support of her institution to carry out her
research.
This proposal outlines a 5-year research and career development plan that will prepare Dr. Lee to become an
independent physician-scientist engaged in cutting-edge scientific research. This project aims to elucidate the
mechanisms by which loss of granulocyte-macrophage colony-stimulating factor (GM-CSF) signaling impairs
clearance of surfactant in alveolar macrophages. Dr. Lee’s prior work suggests that reduced expression of GM-
CSF-dependent ABCG1, an intracellular cholesterol transporter that requires ATP to function, may drive
reductions in cholesterol export by alveolar macrophages. Recent evidence, however, also suggests that
reduced ATP production caused by impaired GM-CSF-dependent fatty acid catabolism may contribute to
reduced phospholipid catabolism and/or cholesterol clearance. In Specific Aim 1, Dr. Lee will define the temporal
sequence and kinetics of lipid abnormalities caused by loss of GM-CSF stimulation in vivo with a novel, inducible
mouse model to identify the primary, pathogenic lipid abnormality and the secondary changes. Further, she will
evaluate whether reducing cholesterol content in alveolar macrophages will restore their function to demonstrate
that cholesterol accumulation due to impaired cholesterol clearance is the primary pathologic defect driving
alveolar macrophage dysfunction seen in PAP. Aim 2 will focus on determining the mechanism of the primary
and secondary lipid abnormalities caused by impaired GM-CSF signaling. Improved understanding of the
relationship between loss of GM-CSF signaling and lipid dysregulation leading to surfactant accumulation will be
crucial to the development of effective, innovative therapeutic strategies for patients with PAP and enhancing
the fundamental knowledge of alveolar macrophages.

Public health relevance
Project Narrative Despite recent advances in therapeutic options showing promising results for patients with pulmonary alveolar proteinosis (PAP), there is still no FDA-approved therapy, and not all patients respond to these therapies. There is a critical need to understand the pathogenic mechanisms that underlie PAP in order to develop novel therapies. This proposal is the first step to unveil these mechanisms by evaluating how disruption in granulocyte- macrophage colony-stimulating factor signaling leads to lipid dysregulation and surfactant accumulation in the alveolar space.